Functional changes in secreted RNA biogenesis using in vivo colon tumor models

A major premise of this proposal is that RNAs present in biofluids represent a window into various cellular processes that exist in multiple tissues that release such RNAs. We have found that oncogenic KRAS mutations that occur in colorectal cancer can regulate miRNAs, mRNAs and long RNAs secreted from tumor cells in exosomes. This project (project 1) will determine what the mechanisms are by which these RNAs (cRNAs) enter the bloodstream using in vivo models and how these RNAs change with oncogenic mutations. This project will result in the creation of new tools to visualize and analyze such RNAs in real time and from blood samples in mouse models. We propose the following aims to address these questions.

Public health relevance
We have found that mutations that are associated with the progression of colon cancer leads to changes in RNAs secreted from cells packaged inside vesicles called exosomes that can travel into the bloodstream. We will perform experiments in living organisms and create tools to assay for and visualize these RNAs and understand how these RNAs get into the blood. This will create new tests for presence and treatment of colon cancer.